AR-623 (LIPOSOMAL-TRETINOIN) IN PATIENTS WITH ACUTE PROMYELOCYTIC LEUKEMIA

The purpose of this stud yis to estimate the effectiveness of AR-623 inducing a complete remission in first relapse acute promyocytic leukemia (APL) patients who have not received oral all-trans-retinoic acid (ATRA) within one year.